Evaluating EEG as a diagnostic and prognostic biomarker in Malawian children with febrile coma

Abstract
Coma with fever is a common clinical presentation for children living in resource-limited countries. In endemic
areas, malaria is the most common cause. We previously established that EEG is a prognostic biomarker in
pediatric cerebral malaria (CM). In this research, we will use data previously collected as part of an
observational study enrolling Malawian children with non-malarial coma to identify if EEG is a diagnostic and
prognostic biomarker in this patient group. We will evaluate whether there are differences in EEG studies in
children with non-malarial coma and CM (a diagnostic biomarker). We will evaluate if there are EEG factors
associated with hospital discharge outcomes in children with non-malarial febrile coma (a prognostic
biomarker), as we did in our previous studies from children with CM. If EEG factors are associated with
outcomes in children with non-malarial coma, we will compare them to the EEG factors associated with
outcomes in children with CM. The results of this research may allow better clinical care of children with febrile
coma, as it may help determine if the underlying cause of illness is malaria or non-malarial. It may help
determine, at the time of admission, if a child with non-malarial coma is at higher risk of an adverse outcome.

Public health relevance
Project Narrative The goal of the proposed research is to evaluate whether an admission electroencephalogram (EEG) is a diagnostic and prognostic biomarker for Malawian children with fever and coma. We will evaluate whether EEG can differentiate whether coma with fever is due to malaria or from another source. We will evaluate whether there are EEG factors that can be used to predict outcomes in children with coma and fever who do not have malaria parasites in their blood, just as we did in previous research studies of children with cerebral malaria.